Moving Forward with Multiple Myeloma

PROJECT SUMMARY
Multiple Myeloma (MM) is the second most common hematological malignancy in the U.S., typically diagnosed
in older adults and disproportionately affecting African Americans (AA). Treatment advances, such as frontline
autologous stem cell transplant (ASCT) and a growing list of novel therapies such as proteasome inhibitors,
immunomodulatory drugs, and immunotherapies have changed MM from being an imminently fatal condition to
that of a chronic disease, such that patients are now treated continuously. Five-year survival rates have
increased from 32% to 58% over the last two decades. Pre-existing co-morbid conditions (e.g., obesity,
hyperlipidemia, hyperglycemia), on-going treatment toxicity, symptom burden (e.g., fatigue), as well as bone
instability, muscle loss, and immobility are common; all of which collectively and negatively impact physical,
emotional, and social health. Physical functioning naturally decreases with age and is negatively associated
with adverse body composition phenotypes. Consequently, as shown by our group and others, sarcopenia (low
muscle mass and function) and/or sarcopenic obesity (low muscle mass and function plus high adiposity) are
highly prevalent at MM diagnosis, and predict fatigue, increased risk of falls, and shortened overall survival.
Therefore, lifestyle interventions targeting physical functioning would likely have numerous performance-based
and patient-reported benefits for these survivors, yet this remains largely unexplored. Moving Forward with
Multiple Myeloma, will examine the efficacy of a 16-week lifestyle intervention, on physical function (primary)
and patient-reported outcomes (secondary) among 184 (24% Black/AA) individuals with stable MM. We will
also explore associations between lifestyle behaviors and prognostic tissue (body composition), serum
(indicators of metabolic health and inflammation), and novel cellular biomarkers (cell senescence). This trial is
grounded in significant developmental work exploring the needs and interests of MM survivors and establishing
a Patient and Community Advisory Board to guide the proposed work. We have assembled a highly qualified,
multidisciplinary study team (behavioral scientist, nutrition scientist, physician-scientist, clinical exercise
physiologist, patient-reported outcomes expert, biological aging expert, and biostatistician) and will leverage
our extensive expertise in intervention trial implementation. We propose several biologically plausible
mechanisms to explore how lifestyle behaviors work in concert to influence highly relevant outcomes for MM
survivors. Thus, this study reflects a critical step in a research trajectory to help discern how lifestyle behaviors
can assist myeloma survivors move forward in their journey toward better health as they live longer with the
chronic burdens of their cancer and related therapies.

Public health relevance
Project Narrative Treatment advances for multiple myeloma, the second most prevalent hematological malignancy in the United States, have transformed this once imminently fatal disease into a chronic illness. With 5-year survival rates increasing from 32% to 58% over the last two decades, efforts to address survivorship concerns are needed. The proposed study examines the effects of a lifestyle intervention on performance-based physical function, patient-reported outcomes, and associated physiological pathways including body composition, general health indicators, inflammation, and biological aging.